The role of the microbiome in hepatic encephalopathy pathogenesis and treatment

Project Summary/Abstract
Hepatic encephalopathy (HE) is a complication of cirrhosis characterized by cognitive, psychological, and
motor dysfunction that is associated with decreased quality of life and poor survival. Unfortunately, current
treatments for HE only have modest efficacy in preventing overt (or clinically apparent) HE episodes. Novel
therapies are desperately needed to alleviate the burden of HE, and targeting the microbiome is a promising
therapeutic pathway. HE is thought to result from translocation of bacterial products across a permeable
intestinal epithelium, which bypass the dysfunctional liver and reach the brain. Dr. Bloom’s preliminary work
shows that specific gut bacteria are associated with impaired intestinal barrier function and may influence HE.
Despite this initial work, there is limited data regarding the most promising microbiome targets for HE treatment
– a gap that Dr. Bloom plans to address in this proposal. Her central hypothesis is that microbiome-targeted
therapies can treat and prevent HE. Her aims are to 1) identify host and microbiome features associated with
future overt HE, and 2) compare mechanisms of microbiome-targeted therapies to treat minimal HE. In order to
accomplish Aim 1, she will conduct a prospective cohort study that will enroll 150 patients with cirrhosis: 75
patients with a history of overt HE and 75 patients with no history of overt HE but at high risk. At baseline, she
will collect microbiome and host data. She will then prospectively follow all patients for 6 months to identify
interval overt HE, while collecting serial microbiome and host data. In order to accomplish Aim 2, she will
conduct a pilot clinical trial in 60 patients with cirrhosis and minimal HE. She will randomize patients to 1)
lactulose (standard of care), 2) polyethylene glycol (used as alternative to standard of care), or 3) potato
starch. She will evaluate microbiome composition and function and cognitive function before, during, and after
therapy. The primary outcome will be change in stool short-chain fatty acids with treatment. These proposed
studies will identify host and microbiome features closely associated with HE and determine the impact of HE
therapies in reversing HE-associated microbiome features. During the K23 award period, Dr. Bloom will
acquire knowledge and skills in three core research domains: rigorous clinical trial design, microbiome
sequencing analysis, and statistical modeling. She will achieve these training goals through hands-on
mentorship, a Masters in Public Health, other formal didactics, several regular group meetings, and attending
academic conferences. Dr. Bloom will specifically learn how to perform clinical trials of microbiome-targeted
therapies, analyze metagenomic sequencing to interpret bacterial community composition and function, and
develop multi-dimensional models that include multi-omics (microbiome and metabolome) and longitudinal
data to better understand the pathogenesis of HE and mechanism of microbiome-targeted therapies. Through
this K23 career development award, Dr. Bloom will achieve her long-term goal of becoming an independent
clinical and translational investigator who can design and lead trials of microbiome-targeted therapies for HE.

Public health relevance
Project Narrative One-third of patients with cirrhosis will develop a complication called hepatic encephalopathy, which is characterized by confusion, fatigue, and personality changes – all of which significantly decrease quality of life and patient survival. Current treatments are only moderately effective, but there is some data suggesting that intestinal bacteria may play an important role in causing hepatic encephalopathy. This project uses novel approaches to identify the importance of intestinal bacteria in hepatic encephalopathy, and tests if treatments that influence intestinal bacteria can treat this condition.